HIV-1 Q23.17 Env: Engineering a novel immunogen to elicit broadly neutralizing antibodies

PROJECT SUMMARY
In humans, neutralizing antibodies elicited by HIV-1 coevolve with viral Envs in distinctive patterns, in some
cases acquiring substantial breadth. We found that primary HIV-1 Envs, when expressed by simian-human
immunodeficiency viruses (SHIVs) in 22 rhesus macaques (RMs), elicited patterns of Env-Ab coevolution
strikingly similar to those in humans (Science 371:eabd2638, 2021). This included conserved immunogenetic,
structural and chemical solutions to epitope recognition and precise Env-amino acid substitutions, insertions and
deletions leading to virus persistence. The structure of one rhesus antibody, capable of neutralizing 49% of a
208-strain panel, revealed a V2-apex mode of recognition like that of human bNAbs PGT145 and PCT64. We
subsequently expanded this study to include 150 RMs infected by SHIVs bearing any of 15 different primary
HIV-1 Envs; 24 (16%) of these animals developed bNAbs targeting conserved V2 apex, V3 glycan, CD4bs or
fusion peptide epitopes. The V2 apex was the most common bNAb epitope targeted in RMs. We concluded that
Env-Ab coevolution in RMs recapitulates developmental features of human bNAbs and may serve to guide and
accelerate HIV-1 immunogen design for humans. From these preclinical data, we identified HIV-1 Q23.17 Env
as the immunogen that most consistently elicited V2 apex bNAbs. Here, we propose to elucidate the Env-Ab
coevolutionary pathways by which HIV-1 Q23.17 Env selectively primes, boosts and affinity-matures V2 apex
bNAb responses and to translate these findings into an all-SOSIP Env trimer vaccine regimen consisting of a
germline-targeted Q23.17 Env prime followed by boosts with lineage-designed Q23.17 Env “imunotypes”
capable of affinity-maturing B cells to achieve breadth. Specific aims are: (i) to decipher molecular pathways of
Env-Ab coevolution in SHIV.Q23.17 infected RMs that lead to the development of V2 apex bNAbs, including the
identification of inferred germline bNAb precursors and lineage intermediates and corresponding Env
immunotypes that bind to them; (ii) to use mammalian display saturation mutagenesis to generate Q23.17 Env
variants that exhibit enhanced binding affinity to multiple rhesus germline V2 apex bNAb B cell precursors and
to engineer these Envs as nanoparticle-delivered SOSIP trimers; (iii) to test the immunogenicity of germline-
targeted and lineage-designed Q23.17 Env SOSIP trimers in V2 apex bNAb UCA knockin mice and outbred
RMs and to advance the most promising combinations to a proof-of-concept preclinical vaccine trial in RMs; and
(iv) to conduct an appropriately powered preclinical vaccine trial in 28 RMs to test the hypothesis that reverse-
engineered, B lineage-designed Q23.17 SOSIP Env trimers can prime, boost and affinity mature V2 apex bNAb
responses in RMs to an extent that is superior to conventional SOSIP Env immunogens and that protects RMs
from heterologous virus challenge. The significance of these studies could be far-reaching: if we can demonstrate
consistent induction of bNAbs using germline-targeted, lineage-designed Q23.17 Env SOSIPs in RMs, it would
represent a new beachhead for HIV-1 vaccine research that could be translated rapidly into human clinical trials.

Public health relevance
PROJECT NARRATIVE A major obstacle to rational HIV-1 vaccine design is the lack of an outbred primate animal model where the induction of broadly neutralizing antibodies (bNAbs) can be achieved in a consistent and reproducible manner and the molecular events leading to bNAb elicitation deciphered. This application proposes a novel “reverse vaccinology” strategy to overcome this roadblock leading to new immunogen designs and a pivotal proof-of-concept preclinical immunogenicity and protection trial in rhesus macaques. This trial will test the ability of a germline-targeted Q23.17 SOSIP Env prime, followed by lineage-designed Q23.17 SOSIP Env trimer boosts, to elicit bNAbs that protect monkeys from a heterologous tier 2 virus challenge.